TENTH INTERNATIONAL PAPILLOMAVIRUS WORKSHOP

This proposal requests funds to help support the travel and accommodation expenses of 20 U.S. scientists and 5 foreign scientists to attend the Tenth International Papillomavirus Workshop to be held in Seattle, Washington from July 20, 1991 through July 26, 1991. The topics for discussion will cover all aspects of the biology and molecular biology of papillomaviruses as well as the characteristics of the human papillomaviruses as infectious agents and etiologic agents in anogenital cancer. The workshop will be composed of 15 sessions covering transformation, gene expression, replication, immunology, diagnosis, pathogenesis and epidemiology. There will also be a series of "in-depth" workshops on detection, treatment, serology, nomenclature and regulation.